Using a Superoxide Dismutase Mimetic to Mitigate Age-Associated, Radiation-Induced Cardiopulmonary Damage: Investigating the Role of Nitro-Oxidative Signaling and Mitochondrial Metabolism

PROJECT SUMMARY/ABSTRACT.
An aging population faces unique health challenges, including increased susceptibility to ionizing
radiation (IR) toxicities due to oxidative and nitrative metabolic changes. Elderly individuals are particularly
vulnerable to IR-induced cardiopulmonary toxicities due to age-related physiological changes that impair tissue
repair and regeneration. Age-associated decline in metabolic efficiency generates increased reactive oxygen
species [i.e., superoxide (O2•−)]. IR exposure may also induce bursts of O2•− and nitrative species [i.e., nitric oxide
(NO)]. Excess O2•− can combine with NO to form peroxynitrite (ONOO-) that can damage proteins, lipids, and
DNA leading to inflammation and fibrosis. O2•− can disrupt the mitochondrial electron transport chain (ETC)
complexes I and III while ONOO- inhibits mitochondrial ETC complex II. Inhibition of the ETC complexes leads
to increased residence time of electrons at specific sites in the ETC, disrupting ETC stoichiometry and further
increasing O2•− formation, resulting in a state of persistent oxidative stress and subsequent cardiopulmonary
damage. This proposal investigates the age-associated impact of nitro-oxidative metabolism on mitochondrial
ETC complex efficiency and cardiopulmonary physiology. Utilizing genetically modified mice and an upper body
irradiation (UBI) model, we will elucidate the impact of nitric oxide synthase 1 (Nos1) disruption and assess the
efficacy of a superoxide dismutase mimetic (Rucosopasem) in ameliorating age-associated cardiopulmonary
effects induced by IR. We hypothesize that age-associated, IR-induced disruptions in the assembly of
mitochondrial complexes result in stochiometric mismatches and alterations in the generation of O2•− and ONOO-
leading to differential IR-induced cardiac and pulmonary phenotypes based on age. Aim 1 will define the age-
associated effects of UBI on the stoichiometry of the ETC complexes in WT and Nos1+/- murine models and the
effects on cardiopulmonary pathophysiology. Aim 2 will determine the efficacy of a clinically relevant superoxide
dismutase (SOD) mimetic, Rucusopasem, to target the alterations in mitochondrial ETC stoichiometry, reduce
ONOO- and O2•− formation, and mitigate the age-related IR-induced effects on the cardiopulmonary system.
Completing these studies may unveil age-associated differences in nitro-oxidative metabolism and mitochondrial
dysfunction, potentially identifying targets to prevent or reduce IR-induced cardiopulmonary toxicities. Moreover,
if treatment with a superoxide dismutase mimetic restores ETC complex function, this will identify a potential
countermeasure strategy to mitigate IR-induced cardiopulmonary toxicities.

Public health relevance
NARRATIVE The aging U.S. population faces increased vulnerability to ionizing radiation-induced toxicities due to disruptions in mitochondrial bioenergetics and function. With aging, the production of reactive oxygen (e.g. superoxide) and nitrogen (e.g. peroxynitrite) species increase, impairing mitochondrial electron transport chain complex assembly and function. Thus, clinically relevant superoxide dismutase mimetics may hold promise as countermeasures to mitigate ionizing radiation-induced toxicities.